LIAISON BETWEEN AUGUSTANA COLLEGE AND SD BRIN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Due to the reassignment of Dr. Wanous to administration at Augustana College, former SD BRIN program coordinator and now retired biology professor Dr. Maureen Diggins reassumed her role as the liaison between Augustana College and SD BRIN for one year. She attended meetings of the Steering Committee, prepared the institutional annual report information, and served on the Selections Committee for summer fellows.